Web-based CBT for Insomnia in Rural Dementia Caregivers: Examination of Sleep, Arousal, Mood, Cognitive, and Immune Outcomes

PROJECT SUMMARY
Compared to their urban counterparts, rural family dementia caregivers (CGs) face increased vulnerability to insomnia and
related health concerns (stress, inflammation, depression, anxiety, cognitive disturbance). Cognitive behavioral treatment
for insomnia (CBT-I) holds promise for improving insomnia and these related concerns, but is difficult to access in rural
areas. Our team developed brief telehealth CBT-I (tele bCBT-I) tailored for CGs (e.g., includes stress management/problem
solving) that improved sleep, arousal, mood, cognition and inflammation (small to large effects). While telehealth improves
accessibility, it is still burdensome for CGs due to inflexible scheduling and scarcity of trained therapists. Thus, more
research is needed. Web delivery would increase access and web CBT-I is efficacious in non-CG adults, but has not been
tested in rural CGs. Using the NIH Stage Model flexible framework and Medical Research Council recommendations, we
developed NiteCAPP (web translation of our tele bCBT-I protocol). Stage IA/B validation and testing show high feasibility
and acceptability, and improvements in sleep, arousal, mood, burden and cognition in a single arm pilot in rural CGs (n=5).
The proposed trial is the next logical step - Stage II testing in an RCT (n=100) to establish efficacy and further evaluate
feasibility and acceptability. The Cognitive Activation Theory of Stress provides a framework for our basic premise that
CGs experience insomnia, arousal and inflammation that prompt sympathetic activation and hypothalamic-pituitary-adrenal
(HPA) disruption that have downstream negative effects on health. The proposed trial tests the novel hypothesis that
NiteCAPP will improve CG health, mood, burden and cognition by targeting their shared underlying mechanisms – sleep,
arousal and inflammation – thereby, returning sympathetic and HPA functioning to normal. Another novel aspect of the
proposed trial is inclusion of behavioral strategies to target the person with dementia’s (PWD) sleep. Outcomes will be
assessed at baseline, post-treatment and two follow-ups (6 and 12 months) and include CG sleep, arousal, inflammation,
health, mood, burden and cognition, and PWD sleep.
The proposed study has four specific aims. Aim 1 focuses on the feasibility and acceptability of NiteCAPP and
WebSHE (sleep hygiene education – active web comparator). Aims 2 and 3 examine NiteCAPP’s effects (versus WebSHE)
on CG primary/mechanistic (sleep, arousal, inflammation) and secondary outcomes (health, mood, burden, cognition),
respectively. Because the PWD’s sleep impacts CG sleep, Aim 4 examines NiteCAPP’s secondary effects on PWD sleep
(objectively assessed). An Exploratory Aim examines the relationships between changes in CG primary and secondary
outcomes, and their potential mediators/ moderators.
Public Health Implications: Demonstration that rural CGs can use NiteCAPP to target sleep, arousal/stress, inflammation
and related health concerns has important implications for multiple stakeholders, including rural CGs, rural PWDs, their
families, clinicians and policymakers.

Public health relevance
PROJECT NARRATIVE This trial uses internet technology and community methods to test the acceptability, feasibility and efficacy of NiteCAPP, a brief web CBT-I for rural dementia caregivers (CGs). It offers new understanding of how NiteCAPP improves CG sleep, arousal and inflammation and prompts downstream effects on other outcomes (health, mood, burden, cognition). Demonstration that rural CGs can use NiteCAPP to target sleep, arousal, inflammation and related concerns has important implications for rural CGs/PWDs, their families, clinicians and policymakers.